Using the Collaborative Cross to Understand the Impact of a High-Fat Diet on the Adipose Tissue Invariant Natural Killer T Cell Compartment

PROJECT SUMMARY Obesity is rapidly becoming a global epidemic. Obesity drives inflammatory processes in the body's visceral white fat. This inflammation acts systemically to promote “metabolic syndrome”, a confluence of clinical manifestations including insulin resistance and high blood sugar, high levels of cholesterol and triglycerides in the blood, hypertension, and cardiovascular disease progression. A white blood cell central to this process, the invariant natural killer T cell (iNKT cell), interacts directly with fat cells to depress inflammation. iNKT cell abundance in fat varies between genetically diverse mouse strains and between human patients. However, for reasons not yet understood, these important immune regulatory cells are lost from white fat as individuals (both mice and humans) transition from a lean to an obese state. Most of our knowledge of regulation of white fat comes from studies of a single inbred mouse strain. To better understand the functioning of the immune system of white fat, we will study fat cells in a mouse population (Collaborative Cross; CC) that models levels of genetic diversity found in humans. We hypothesize that strain-dependent differences in fat iNKT cell abundance affect the consequences of high fat diet-driven inflammation. To address this hypothesis, we will create an unbiased, comprehensive cellular atlas of the white visceral fat in strains representing each of the three subspecies that contributed ancestry to the CC (Aim 1). We will use cutting edge technology, single cell RNA-Seq, to build this atlas, which will result in a catalog of the cells present in white visceral fat and an understanding of the heterogeneity of each cell population. Furthermore, we will use the CC resource at The Jackson Laboratory along with our cellular atlas of the visceral white fat to examine 36 genetically diverse CC strains of mice fed either a normal or high fat diet. We will determine the effect of high fat diet on the immune cell composition of white visceral fat in addition to examining mice for signs of metabolic syndrome (Aim 2). Our focus will be on the role of iNKT cells as members of a complex immune cell network, where cells communicate with each other and can influence the behavior of other cells. By correlating immune cell abundance and indicators of metabolic disease, we will gain insight into the immune regulation of visceral fat. Furthermore, this survey of 36 strains will yield strains where high fat diet-induced cellular changes diverge in direction or magnitude from previously observed patterns, which would constitute valuable new models for studying immunoregulatory mechanisms relevant to many diseases exacerbated by obesity. Overall, the proposed project will lay the groundwork for future studies examining the detailed mechanisms through which the immune system regulates visceral white fat and identifying potential therapeutic targets for the many diseases associated with metabolic syndrome.

Public health relevance
PROJECT NARRATIVE Obesity increases the risk of developing multiple diseases, including autoimmunity, insulin resistance, type 2 diabetes, and hypertension, through inflammatory processes occurring in lipid-stressed visceral white adipose tissue. Our proposal seeks to use the Collaborative Cross mouse diversity resource to better understand how host genetic diversity impacts immune regulation of adipose tissue.